Emory/Georgia TB Research Advancement Center (TRAC)

The Bioinformatics and Integrated Systems Biology (Systems Biology) Core will represent an integral
component of the Emory/Georgia TRAC. While individual members of the Emory/Georgia TB research
community have strong records of collaborative TB research, access to cutting edge methods in systems
biology have not been easily accessible. Although the partner institutions of the Emory/Georgia TRAC host a
wide variety of Core facilities performing ‘-omics’ assays, expertise in computational biology needed to analyze
and integrate the high-dimensional, multiscale data sets produced by these platforms is often not readily
available. We propose to provide essential support for high-dimensional, multiscale data analysis and
integration to facilitate use of ‘-omics’ technologies among Emory/Georgia TRAC investigators. The Systems
Biology Core will accomplish this by serving as a single point of contact (concierge function) to investigators of
the Emory/Georgia TRAC, and facilitating access to a wide array of ‘-omics’ technologies for specific
experimental designs. Using established computational pipelines, we will provide training to new investigators
on methods in high-dimensional data analysis and data integration in this increasingly essential area of basic
and translational research. The specific aims of the BISB Core are: 1) to provide a single point of contact
structure for data acquisition, management, and analysis for all ‘-omics’ platforms to TRAC investigators; 2) To
provide training and educational resources to TRAC members to carry out cutting edge experiments using ‘-
omics’ technologies and implement associated computational pipelines; and 3) to develop and implement
novel multiomics assays and associated computational models to advance TB research. We will strive to
nurture a collaborative research environment among Emory/Georgia TRAC investigators by facilitating the use
and implementation of cutting edge multiomics assays to advance TB research and train the next generation of
TB researchers.